Administrative Oversight

ADMINISTRATIVE OVERSIGHT – PROJECT SUMMARY / ABSTRACT
The overall goal of the Administrative Oversight component (Admin Oversight) is to coordinate the
development and high impact functioning of a national center (NC) at the Medical University of South Carolina
(MUSC) to support researchers in the field of neuromodulation for rehabilitation (NM4R). In order for the NC
NM4R to exert a sustained, powerful influence on the field of NM4R, we oversee numerous individual component
functions to ensure a cohesive program that aligns with the needs of the research community and actively
contributes to the coalescing of research priorities. The PD/PI leads Admin Oversight and manages all necessary
functions with input and assistance from the Executive Committee who have diverse expertise and experience
in NM4R, and the External Advisory Board (comprised of 5 eminent scientists who represent the broad NM4R
research community and provide objective oversight, evaluation, and strategic interactions to optimize the
Center’s impact). Admin Oversight integrates diverse visionary leadership, sound operations and fiscal
management, coordination with NCMRR program staff and Network centers, and a multifaceted evaluation plan
to ensure NC NM4R success. Our work is organized under these Specific Aims:
AIM 1. Leadership and Oversight. The Executive Committee (EC) provides balanced leadership, program
integration, oversight and accountability for all NC NM4R programs, services, and interactions.
AIM 2. Strategic Planning and Collaboration. Our guiding principle is that the center must impact the NIH
Research Plan for Rehabilitation (RPR) priorities. Thus, the organizing structure and operational plan serve to
ensure this impact – from decision-making processes that require explicit mapping of investments to RPR
priorities, to a robust evaluation program that ensures responsiveness to the rehabilitation research community.
AIM 3. Operations and Fiscal Management, The PD/PI oversees an administrative infrastructure that ensures
efficient implementation of Executive Committee decisions, sound fiscal management, and compliance with
federal and local regulations.
AIM 4. Program Evaluation. The Evaluation Director is responsible for developing an integrated, long-term
evaluation plan to ensure quality control of programs and continual improvement responsive to research
community needs as well as document the impact of the NC NM4R on the research community.
AIM 5. Prioritizing Investigator/Collaboration Opportunities and Pilot Study Funding. This aim defines the
framework for acceptance for workshops, advanced hands-on training programs and consultative services. The
EC also prioritizes individual pilot studies for funding. In each of these functions, the EC acts like an NIH Council,
setting priorities based on the results of a first-level merit review by a separate review group and strategic criteria.
AIM 6. Diversity Planning. The Executive Committee is responsible for approving diversity recruitment and
retention strategies to be operationalized by the Program Manager under the PD/PI’s oversight.